Role of Stat3 in Colonic Inflammation

DESCRIPTION (provided by applicant): Inflammatory bowel disease (IBD) affects approximately 1.4 million people in the United States. The pathogenesis of IBD is thought to involve an exaggerated immune response to the colonic flora in the genetically susceptible host. When IBD, either ulcerative colitis or Crohn's disease, affects the colon and/or rectum, patients are at a signficantly [sic] higher risk of developing colitis associated-colorectal cancer. In patients with pancolitis for greater than 20 years the risk of cancer approaches 20%. Although colonic epithelial cell genetic and epigenetic alterations are inevitable in colitis associated cancer, what triggers colonic epithelia cell oncogenic transformation is poorly understood. We found that Min (APC ) mice colonized with an human colonic commensal, enterotoxigenic Bacteriodes fragilis (ETBF) demonstrate marked colonic inflammation and rapid colon tumor formation dependent, in part, on a predominant and selective Th17 response with early activation of signal transducer and activator of transcription 3 (Stat3) in colonic epithelial cells and immune cells. These results support the hypothesis that the microbiota can precipitate specific mucosal signaling and immune responses important in early neoplastic changes in IBD. We further hypothesize that Stat3, a key oncogenic transcriptional regulator, is a coordinate regulator of the epithelial and mucosal immune signaling and is critical to colon inflammation and, ultimately, tumorigenesis. The goals of this project are: 1. To define in ETBF-infected mice, how Stat3 activation in distinct cell types (lymphocytes, colonic epithelial cells and myeloid cells) contributes to coitis [sic] and 2. To define the mucosal immune profile (Th1/Th17 balance) in IBD patients who develop dysplasia and/or colitis-associated cancer compared to controls. These integrated mouse and human experiments, that will be completed under the mentorship of Dr. Cynthia Sears, expert in bacterial pathogenesis, and Dr. Drew Pardoll, expert in tumor immunology, will provide the applicant with practical experience in state of the art pathogenesis and immunology research methods. To complete gaps in her knowledge, the applicant has designed a complementary didactic program in immunology and translational research design. Together the practical and didactic experience gained by completing this career development plan will enable the applicant to transition to an independent investigator over the next five years.

Public health relevance
PUBLIC HEALTH RELEVANCE: Inflammatory bowel disease (IBD) affects approximately 1.4 million people in the United States. When IBD, either ulcerative colitis or Crohn's disease, affects the colon and/or rectum, patients are at a signficantly [sic] higher risk of developing colorectal cancer. In patients with pancolitis for greater than 20 years the risk of colorectal cancer approaches 20%. Understanding the relationship between intestinal inflammation and colonic neoplasia may help in identifying strategies for preventing cancer in IBD patients and for treating colitis associated cancers. Inflammatory bowel disease (IBD) affects approximately 1.4 million people in the United States. When IBD, either ulcerative colitis or Crohn’s disease, affects the colon and/or rectum, patients are at a signficantly higher risk of developing colorectal cancer. In patients with pancolitis for greater than 20 years the risk of colorectal cancer approaches 20%. Understanding the relationship between intestinal inflammation and colonic neoplasia may help in identifying strategies for preventing cancer in IBD patients and for treating colitis associated cancers. __SpecificAimsTextDelimiter__ A. Hypothesis and Specific Aims. Inflammatory bowel disease (IBD) is an enigmatic condition the pathogenesis of which is thought to involve an exaggerated immune response to the colonic flora in the genetically susceptible host. One of the most serious sequelae of chronic IBD is the development of colitis-associated cancer (CAC). Although colonic epithelial cell (CEC) genetic and epigenetic alterations are inevitable in CAC, what triggers CEC oncogenic transformation is poorly understood. The colonic flora is thought to contribute to both colitis and colon tumorigenesis, but the specific bacterial species and mechanisms have remained elusive. Recent collaborative studies between the Sears and Pardoll groups (co-mentors for the applicant, Dr. Wick) have demonstrated dramatic enhancement of colon tumor formation in MinAPC+/- mice (multiple intestinal neoplasia mice) colonized with the anaerobic human colonic bacteria, enterotoxigenic Bacteroides fragilis (ETBF), which can cause acute colitis, but are also asymptomatic commensals in up to 30% of adults.12 ETBF cause colitis by secreting a metalloproteinase toxin termed Bacteroides fragilis toxin (BFT). In this model, tumor induction occurs, in part, via activation of CEC and immune cell Stat3, leading to a colonic mucosal immune response characterized by IL-17 production by a unique T cell subset, termed Thelper 17 (Th17) (see below, preliminary data). Although host and environmental factors contribute to IBD, much of the intestinal pathology is mediated by aberrant immune responses. While ETBF colonization may or may not be etiologic in human IBD and/or CAC, the murine model of ETBF colonization defines a potential common mechanistic pathway linking colonic immune responses to CAC development. Both IL-17 and Th17 cells contribute to intestinal homeostasis and dysregulation of this helper T cell subset has been noted in animal models of colitis and patients with IBD. Our general hypothesis is that Stat3, a key oncogenic transcriptional regulator, is a coordinate regulator of CEC and mucosal immune signaling that is critical to colonic inflammation and, ultimately, colon tumorigenesis. This project, supported by the readily available animal models and clinical cohorts, provides a unique opportunity to test this hypothesis in mice and humans in a parallel and complementary fashion. The specific aims of this project are: Aim 1: To investigate the mechanism(s) by which Stat3 activation contributes to colon inflammation using C57Bl/6mice. Hypothesis 1: Stat3 activation in distinct cell populations (T cells, myeloid cells and CECs) interacts and contributes to the Th17-dependent inflammatory colitis and, ultimately, tumor formation observed in ETBF- colonized Min mice. To begin to test this hypothesis, a conditional KO approach will be used to define the contribution of select pools of Stat3 to colon inflammation in ETBF-colonized C57Bl/6 mice. Aim 2: To determine whether human CAC specimens display activated Stat3 (determined by a defined tyrosine phosphorylation, pStat3) and whether this correlates with a Th17 immune profile and disease characteristics. Hypothesis 2: Stat3/Th17-dependent inflammation will be associated with CAC and possibly a more aggressive IBD phenotype. To address this hypothesis, two complementary approaches will be used. In the first, pStat3 and IL-17 expression (along with additional cytokines and chemokines associated with Th17 immune response) as well as the antagonistic Th1 profile (induced by pStat1 and 4 activation and associated with interferon-g expression along with IL-12) will be defined and quantified in archived colon tissues from patients with IBD and CAC. In the second, prospectively collected colonic tissues from IBD and CAC will be studied in detail to define Stat signaling and the nature of the associated inflammation. These studies will systematically define the role of compartment-specific Stat3 in the inflammation-driven by ETBF colonization of C57Bl/6 mice and will begin to identify if Th1/Th17 mucosal immune balance in patients with IBD and CAC may contribute to neoplasia. The findings will lay the groundwork for novel mechanism- based interventional approaches to preventing and/or treating IBD and/or CAC. This proposal will allow the applicant to gain experience in mucosal immunology and leverage my clinical practice in IBD and colorectal cancer surgery to initiate a translational study of early neoplastic changes in colorectal cancer that she expects will provide the data to submit for subsequent R01 NIH support.